Local Food Safety Collaborative

PROJECT SUMMARY
Instructions:
The summary is limited to 250 words. The names and affiliated organizations of all Project Directors/Principal Investigators (PD/PI) should be listed in
addition to the title of the project. The summary should be a self-contained, specific description of the activity to be undertaken and should focus on:
overall project goal(s) and supporting objectives; plans to accomplish project goal(s); and relevance of the project to the goals of the program. The
importance of a concise, informative Project Summary cannot be overemphasized.
Title: Local Food Safety Collaborative
PD: Wancko, Patricia "Tricia" Institution: National Farmers Union Foundation
CO-PD: PD/PI 2 Name (Last, First, MI) Institution:
CO-PD: PD/PI 3 Name (Last, First, MI) Institution:
CO-PD: PD/PI 4 Name (Last, First, MI) Institution:
CO-PD: PD/PI 5 Name (Last, First, MI) Institution:
CO-PD: PD/PI 6 Name (Last, First, MI) Institution:
CO-PD: PD/PI 7 Name (Last, First, MI) Institution:
National Farmers Union Foundation's (NFUF) project, the Local Food Safety Collaborative
(LFSC), is dedicated to helping local farmers and processors advance their food safety
knowledge and capacity in order to increase compliance, enhance the economic viability of their
operations, and enable them to continue providing consumers with safe, healthy local food.
Building on previous work, LFSC will help local food producer audiences interpret, understand,
and implement Federal food safety regulations and guidance and address challenges to the
implementation of food safety best practices in their operations. Project approach will
encompasses education and training as well as direct assistance that is scale and culturally
appropriate; a particular emphasis will be placed on providing opportunities for peer-to-peer
learning and experiential education. LFSC will work with project partners and producers
themselves to identify needs and develop resources with an emphasis on creating materials in a
variety of media formats that mitigate cultural and learning barriers to knowledge acquisition
and practice. LFSC will continue to collaborate with community-based organizations with
established relationships of trust as well as an understanding of the target audience in their
respective communities. Project methods include:
Collaboration – Facilitate collaboration among relevant community-based farm and food
organizations, academic, and regulatory stakeholders.
Outreach – Conduct outreach to target audience producers to facilitate awareness of food safety
compliance, promote educational opportunities, and disseminate food safety resources.
Education and Training – Deliver food safety education and training that meets target audience
producers where they are.
Resource Development – Develop food safety resources tailored to the needs of the target
audience that reduce barriers to learning and reflect their operations.
Technical Assistance – Provide individualized training and support to target audience
This file MUST be converted to PDF prior to attachment in the electronic application package.

Public health relevance
U.S. Food and Drug Administration (FDA) Center for Food Safety and Applied Nutrition (CFSAN) RFA-FD-22-024: Renewal - Local Food Producer Outreach, Education, and Training to Enhance Food Safety and FDA Food Safety Modernization Act (FSMA) Compliance (U01) Local Food Safety Collaborative | National Farmers Union Foundation April 22, 2022 Project Narrative This project is dedicated to helping local food producer audiences who have a unique place within Food Safety Modernization Act (FSMA) regulations. Local food producers experience challenges as they attempt to understand and satisfy food safety requirements. The Local Food Safety Collaborative (LFSC), remains dedicated to helping local farmers and processors advance their food safety knowle dge and capacity in order to increase compliance, enhance the economic viability of their operations, and enable them to continue providing consumers with safe, healthy local food.